MONOCLONAL ANTIBODIES FOR DEVELOPMENTAL STUDIES

The specific objective of this study is to develop monoclonal antibodies to be used in the study of limb development. The Contractor shall: (1) Organize a monoclonal antibody bank to provide investigators with published monoclonal antibodies that recognize various macromolecular components in the developing limb. (2) Develop well characterized new monoclonal antibodies for inclusion in the antibody bank to the macromolecules, Chondronectin and Fibronectin and where possible also to other macromolecules in the developing limb. For both the published and the newly developed monoclonal antibodies, the contractor must be willing to comply to the species specificity of antibodies required by investigators since most limb development studies are currently being done in only a few animal models. (3) Distribute monoclonal antibodies to limb development investigators for a small fee as directed by the Project Officer. Obtain from investigators and transmit to Project Officer, reports and publications of research in which the monoclonal antibodies have been employed.